Trauma and Inflammation Research Training

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
This is a competitive renewal application for the postdoctoral multidisciplinary basic science Trauma and Inflammation Research Training Program (TIRTP) in the Division of Surgical Research, Department of Surgery, at The Alpert Medical School of Brown University. The Program's goal is to identify, recruit, and train the next generation of Trauma and Inflammation Scientists with particular emphasis on retaining MDs in academic careers. Formal training in research involves the acquisition of the technical, intellectual, philosophical, and ethical habits and abilities of the scientist. Development of these traits in the trainees is the most important goal of the Program. Faculty from the Departments of Surgery (Acute Care, Burns, Cardiothoracic, Trauma); Medicine (Infectious Disease, Pulmonary, Emergency); Orthopaedics; Molecular Microbiology and Immunology; Molecular Biology, Cell Biology and Biochemistry; Therapeutic Sciences and Pathology graduate programs at Brown University, and their respective laboratories, afford trainees ideal opportunities to select areas for research. The Level 1 Trauma and Burn Centers at Rhode Island Hospital provide clinical correlates for basic research. The Program is led by a director who is advised and assisted by an Executive Committee in the selection, guidance, and evaluation of trainees. A co-director assists the director in the day-to-day running of the program and stands in his absence. An Extramural Advisors Panel assures the excellence of the Training Program. Two trainees per year are selected nationally, among residents in any branch of surgery or medicine, and recently graduated PhDs. The Training Program lasts two years. The curriculum includes required courses in Biostatistics, Responsible Conduct of Research, Rigor and Reproducibility, and Scientific Writing, as well as elective courses tailored to the specific needs of the trainees. A faculty mentor and an Advisory Group (modeled after a PhD thesis committee and including an experienced trauma care clinician) provide direction, support, and supervision to the trainee, as well as ensuring the clinical relevance of the research project. The Advisory Group assists the trainee and his/her mentor in designing and implementing an Individual Development Plan (IDP) to guide the trainee’s scientific development. Trainees will have no mandatory clinical responsibilities during the training period. This comprehensive program provides the trainee with the technical and intellectual tools necessary to pursue an academic career in research areas related to trauma and inflammation.

Public health relevance
Trauma continues to be a leading cause of death and disability in the USA. The Program aims to train surgical residents or recently graduated PhDs as the next generation of Trauma Scientists, capable of bringing advances in the understanding of the underlying mechanisms of “trauma disease” and inflammation to the bedside and improving the outcome of trauma victims.